Development of FES+BMI Neuroprosthesis for At-Home Use for Persons with Chronic Tetraplegia

The current proposal aims to develop a for at-home-use neuroprosthesis for restoring brain-controlled
functional hand grasping to Veterans and others living with chronic tetraplegia due to spinal cord injury (SCI).
This system leverages and advances two established technologies – functional-electrical stimulation (FES)
systems for re-animating paralyzed limbs, and intracortical brain-machine interfaces (BMIs) for recording and
discerning motor intent. Our previous work successfully demonstrated a Veteran with chronic tetraplegia using
a simple proof-of-concept FES+BMI system, composed of temporarily implanted intramuscular wires for
movement restoration and an implanted brain electrode for deciphering movement intent, to regain brain-
controlled movements of basic arm and hand movements to perform limited but meaningful activities of daily
living (ADLs), such as self-feeding. We have more recently demonstrated a more advanced system that uses
composite flat-interface-nerve-electrode (C-FINE) cuffs to provide for more selective activation of peripheral
musclesfor FES, and a multi-network BMI system for recording from multiple nodes in the cortical grasp network
(primary motor, premotor, and parietal cortices) to provide for more intuitive brain control of dexterous hand
function. These demonstrations have been limited in that research participants could only use them in the
laboratory. The proposal, leveraging existing and to be enrolled study participants of the ReHAB (Re-connecting
the Hand and Arm to the Brain) clinical trial (NCT03898804) who already have implanted C-FINE and BMI
electrodes, will result in developing a C-FINE based FES system, able to be commanded by multiple modalities
(voice, EMG, and a portable BMI system), that will be demonstrated for use in a home environment.
A major consideration for development of at-home FES+BMI use is that factors unforeseen in the
laboratory may become evident that result in variable system performance. Specifically, it is well known that the
behaviors of individual neurons exhibit nonstationarities that could negative impact decoding the movement
command. Additionally changes in a user's internal state (e.g. attention, stress, fatigue) has been shown to affect
non-invasively recorded brain signals. As a result, neural decoders are recalibrated on a daily basis (and
sometime more often) in regular laboratory use. It is unclear the time of these changes, how these changes
affect neural decoding, and how to best mitigate these potentially deleterious changes during continual FES+BMI
use. The present proposal aims to understand how neural variability (Aim 1), and changes in a user's internal
state (measurable through correlated physiological biomarkers) (Aim 2) can be accounted for in development of
an FES+BMI system for at-home use. Examples of these physiological biomarkers include: 1) heart rate
variability (decreased by stress, increased by attention, decreased by fatigue), 2) blood pressure (increased by
stress and attention), 3) pupil size (dilated under stress or intense attention), 4) blink rate (decreased with intense
attention), and 5) saccade velocity (increased with increased attention and error state).
Finally, the proposal will compare FES movement restoration through use of a portable BMI with a more
standard EMG command option (Aim 3). Participants will use each during the at-home portion of the study, and
will report out measures of satisfaction, perceived ease of use, and personal independence. The study will also
use clinically validated tests of upper extremity function, during regular in-laboratory assessments, to compare
performance of these command options for movement restoration through the FES arm and hand
neuroprosthesis. The success of this proposal will result in the first FES+BMI system suitable for at-home use.
The time is appropriate for this work, and the need is great, and the investigative team is the best in the world to
pursue the aims of the proposal.

Public health relevance
Chronic tetraplegia (long-term paralysis of all four limbs), resulting from high cervical spinal cord injury, disproportionately affects Veterans, robbing them of the capability to perform daily activities on their own. This proposal develops, advances, and combines two technologies to restore functional arm and hand movements: 1) Functional Electrical Stimulation (FES) applies small electrical currents to electrodes in the arm to cause movement. 2) Brain-Machine Interface (BMI) technology uses tiny electrodes implanted in the brain to decipher a person’s intended movements. This proposal combines FES and BMIs into a movement restoration system to be used at home to perform functional activities. The proposal examines methods of increasing the system robustness to changes in brain function and other factors such as stress and fatigue, during at-home use. The proposal’s success will lead to Veterans with paralysis being able to perform functional movements just by thinking about them, thereby giving them greater independence in everyday activities during at-home use.